2020 American Society for Neural Therapy and Repair Conference

Neurodegenerative disorders such as Alzheimer's disease (AD), Huntington's disease and Parkinson's disease (PD), acute disorders such as traumatic brain injury, spinal cord injury, and stroke, and neurodevelopmental disorders such as Angelman's Syndrome, Rett Syndrome, and Spinal Muscular Atrophy are amongst a plethora of devastating neurological conditions for which there are little to no treatments. The financial and emotional burden to patients and their families is indescribable; in addition, the cost of care and lost wages is an enormous financial liability for the US economy. The American Society for Neural Therapy and Repair (ASNTR) is a society focused on basic, translational, and clinical aspects of neurological disorders. The ASNTR membership uses cell transplantation, gene therapy, tissue engineering, neuropharmacology, and other cutting-edge technologies to study and treat such disorders. The 2020 annual meeting of ASNTR will be held at Sheraton Sand Key, Clearwater Beach, FL. This locale provides for a very unique and intimate setting which promotes interactions between junior trainees and accomplished investigators, as well as fostering unique collaborations. The 2020 meeting will be focused on new directions in neural repair and therapy in the coming decade, and the challenges of translating new therapies. As such, planned sessions will cover the “Stem Cell Programming”, “Alzheimer's Disease”, a trainee organized “Who, What, Where, and When to Transplant” and “Emerging Neurotechnologies”. We will hold the annual trainee session for all travel award winners and any member that wishes to attend “Taking the Plunge: Pursuing Translational Research Opportunities available at NINDS” that will feature speakers from the Department of Translational Research at NINDS. Moreover, ASNTR is tremendously committed to trainees. The society encourages trainee participation in the governance of ASNTR and focuses on the development of trainees. The purpose of this R13 is to garner travel support for top trainees (selected from submitted abstracts) to offset their costs to attend the 2020 meeting. Moreover, in 2020 we have several trainee-activities planned. We will also hold a data blitz for trainees as well as meet-the-editor luncheons. Moreover, we have planned social events, aimed at furthering the interaction between faculty and trainees. ASNTR has a strong track record of fostering young investigators, and we aim to continue in this trajectory. Although we always pursue all methods available (i.e. approach the biotech industry and private foundations) in order to provide travel support for trainees, support from the NIH is crucial in order for us to continue on our strong training mission.

Public health relevance
Relevance of this research to public health This application seeks funding for travel awards for graduate students and postdocs to attend the upcoming 27th annual meeting of the American Society for Neural Therapy and Repair. This meeting will promote the interaction between young and senior scientists, as well as clinicians and industry scientists, to jointly discover and develop new treatments for neurological disorders. Commonly at this meeting novel collaborations emerge out of these discussions and this interactive approach between basic scientists, biotech companies and clinicians cultivates a culture of translational research for neurological disorders.